Leveraging CLEERE axial length data to improve myopia treatment

Project Summary/Abstract
The dual objectives of myopia research are to prevent myopia onset and, barring that, to reduce
myopia progression. The field currently has no way to communicate the effectiveness of the
treatments being designed to slow myopia progression other than citing average effects from
clinical trials. Clinicians want to be able to demonstrate to children and their parents the impact
that a treatment is having on an individual child’s myopia. To do this, percentiles of the expected
growth of the eye are necessary. Additionally, the goal of preventing or delaying onset requires
being able to predict who will become myopic. Models currently use basic information from one
time point to make a simple prediction of more likely than not to develop myopia. Clinicians
need an improved model that can assign specific probabilities to individual children in order to
properly identify those whose risk of future myopia justifies starting a preventive treatment. The
CLEERE Study has the largest longitudinal cohort of ocular development across a variety of
race/ethnic groups that will aid in answering these questions. CLEERE provided one of the first
reports on the protective effect of time outdoors, but its effects on axial length have yet to be
described. Using these data to accomplish the following aims will improve the care of these
children.
Specific Aim 1: To analyze axial length data and address critical clinical questions in
myopia control, namely whom to treat and whether treatment is beneficial.
Specific Aim 2: To determine the effect of time spent outdoors/sports activity on axial
elongation before and after myopia onset.
Specific Aim 3: To improve predictive models by determining whether the trajectory of
change in axial length or other ocular components in non-myopic children is a better
predictor of the risk of onset of myopia than spherical equivalent refractive error at a
single point in time.
This NEI Research Grant for Vision-related Secondary Data Analysis (PAR 22-141) will
incorporate statistical techniques not routinely employed in vision research to leverage this large
existing dataset to more fully explore how to give clinicians the tools they need to effectively
treat and manage children’s refractive error.

Public health relevance
Project Narrative As the prevalence of myopia increases world-wide, the long-term result will be an increase in the occurrence of visual impairment related to the longer myopic eye, such as maculopathy. The analyses in this project will support clinicians in their treatment of children in the hopes of reducing myopia prevalence, severity, and potential visual impairment from myopia.